BONE METABOLISM, MORPHOMETRY AND MINERAL CONTENT IN ADOLESCENTS

The aim of this protocol is to compare bone turnover, bone morphometry, and bone density in adolescents with anorexia nervosa and normal controls.